Bacillus subtilis stress responses

Project Summary/Abstract
Bacteria and humans have a complex relationship: our abundant commensal organisms provide
numerous benefits, whereas pathogenic bacteria impose a large burden of morbidity and mortality. The
immune system restricts bacterial growth through nutritional immunity, antimicrobial peptides, lytic enzymes,
and phagocytic cells. Potential pathogens respond to these threats by the activation of specific adaptive
responses, many of which are critical for virulence. We study stress responses in Bacillus subtilis, a model
Gram positive bacterium. One project addresses responses to the changing availability of the essential nutrient
metal ions zinc, iron, and manganese. The immune system restricts the growth of pathogens by metal
sequestration, both in tissues (e.g. by calprotectin) and after phagocytosis. In addition, phagocytic cells kill
cells by metal intoxication. We have demonstrated that metal ion homeostasis relies on specific metal-sensing
transcription factors that respond to limitation and excess of iron (Fur and PerR), manganese (MntR), and zinc
(Zur and CzrA). We will characterize the genes regulated by these transcription factors, their roles in metal
homeostasis, and identify the physiological effects that result from both metal ion limitation and intoxication.
This work will build upon our recent identification of the major efflux systems for both iron and manganese. The
insights from these studies will be directly relevant to the similar stress responses present in human
pathogens. The immune system also restricts the growth of pathogens by production of antibacterial peptides
and lytic enzymes, both of which affect the integrity of the cell envelope. The cell envelope is also a target for
many of our most important antibiotics. In a second project, we have defined several distinct cell envelope
stress responses in B. subtilis, with a focus on those regulated by alternative sigma factors. We have identified
an array of mutants with alterations in stress response pathways and in key central metabolic pathways that
have elevated sensitivity to cell wall antibiotics, including the critically important beta-lactams. In addition, we
explore newly discovered antibiotic synergies with possible implications for clinical approaches. Selection of
antibiotic resistant suppressors provides a powerful approach for delineating the basis of antibiotic synergies,
and the roles of specific stress response pathways. These pathways are central to cell envelope homeostasis
generally, in addition to their role in sensing and responding to antibiotic-induced stress, and are implicated in
the emergence of antibiotic tolerance and resistance in pathogens.

Public health relevance
Narrative The innate immune system restricts the growth of invading bacteria by limiting access to essential nutrient metal ions (nutritional immunity) and by production of antimicrobial peptides and enzymes that attack the cell envelope. Using Bacillus subtilis as a model system, we characterize the bacterial stress responses elicited by metal ion limitation and excess, and by antibiotics that interfere with integrity of the cell envelope. The resulting insights are relevant for understanding the mechanisms that allow bacterial cells (both beneficial and harmful) to adapt to the host environment.